African Bi-Costal (ABC) Cancer Study

01234053
)NT"@S,588==9#>>DB;B=8!A?$TAK$@8O<=A>K!A%=@9@#M+D>@&;;(A->='88=8=4B(;<>B8DRDO=2R979AB"R<=8D9K9@3AQ<*?CDA@(>3,;/L>88.Z8DH@T@DD>1D>;9/ADO=@OD9K<;@>LDR8=U92ADE9PIK@@>A<A,="O89"A>D0=ZJK8*P>9AA(<K8,81@KDT.9K>D"@"Q;L;"M;R;!B=8M;*DR92KN,;?<?.N)>AK/8@@+9<AD@E8AD"A;829K=9R9!AD5"V=3=,>A01O;DOMW>N;3P11K8=S"QD3>>D"3=(=X8B;98[D@9>EL@D?=Y*!;;"??9N;O>?@ND;9O>9=+@,KD;VM4=;9K25PMU$N;WP%KP36>FDNY7=?GK9R@8-NA99;B8:1DX=;=;9<RP==>)@9<=APA88K!+1
D>8^=P9Nf33i nDAOADpJ@fJkLAA(OQ;8@<?9ADD=K=@,UR;39T8?AA8Be;<fEM@g>A8h>JgK9=AiKKfDTj;Ok>=;h@>8Dm;SOAn=9PBo>;nOQ9pTqP!99?D0>@frA<=k@PA7r\A=8o81sP18DgAAAtKK=uAK=4>v;A8k"=APhf9B<oaw5A@LBg;>t@Q>9x;=9fVZtAn!A0KRyM@8>>qD9ZPbg19>O@D<r=KiA<(_z_8#>2p92"`gK`>sNco=P@k;B1PonEA8KAK{NVK9Kk?AMrN?>9jO;#89nP88pA@<K|@<?AvA8>p;}8@1Pdf8}A?<>gP8DWp=@;P1s>D;J=f8D=rBRA\~DA=;!8nRM9r@3<w<;kDARk<_r]2`
9W9111*95199!",9991X!HW9E11909EV899159W""""95559E3/3/33*131*"333F1XX(((883+899319111,399+X5#91"E999999113/91933X1+9V91/W159!#"E5915+\#"91E3!#3,999+$!9539"/195(8#19+9\9+39E
#"*,3+.3$E929!(V893W(931EXWVW"5E3913969+FE959"!+&1+3999W
V9919(8E991(98E99E91,9!9#Y#9+79+8942,;1O;Q;+E=24W3;E@D3QD9919+391+E!E99(W993"E99
89\1!9+E9#+#1933+!7839W:;<1=935E>983?@3A9=X9!901991399,"5*9#,.E3(3!9##9(9999939

Public health relevance
PROJECT NARRATIVE This application is being submitted in response to the Notice of Special Interest (NOSI} identified as NOTCA- 22-036. The applicant parent grant is Florida-California Cancer Research, Education & Engagement (CaRE2} Health Equity Center at the University of Southern California (MPls: Dr. John Carpten and Dr. Mariana Stern), established in 2018 through funding from the NIH/National Cancer Institute (U54CA233465). The primary aim of this supplement award is to strengthen the capacity of an African early stage investigator (ESI) to conduct high-quality research in sub-Saharan Africa and to generate contextappropriate evidence to address the burden of prostate cancer in that region.